Mechanistic understanding of the lifecycle of a circulating hybrid cell.

Project Summary
Metastatic disease accounts for >90% of cancer-related deaths worldwide, yet this phase of tumor progression
is the least biologically understood. The consequence of this lack of knowledge is that we do not have the
appropriate therapeutic arsenal to defeat metastatic cancer. New revelations for colorectal cancer point to shed
neoplastic cells into peripheral blood even from early stage tumors, suggesting this is why some early stage
tumors recur despite seemingly successful treatment. However, whether all early stage primary tumors shed
neoplastic cells, or if only subsets of more aggressive neoplastic cells garner ability to disseminate is not known.
This highlights the critical gap in knowledge of the mechanisms underlying neoplastic cell dissemination leading
to distant disease. Identifying the key features within the lifecycle of a disseminated tumor cell will unravel this
important step in tumor progression with potential to influence management of cancer care. Our study leverages
newly developed state-of-the-art phenotypic analyses of key attributes of a recently discovered neoplastic hybrid
cell in primary tumors and in peripheral blood, termed circulating hybrid cells (CHCs), supported by cutting-edge
computational analyses. Interestingly, CHCs harbor tumor-initiating properties implying that they have high
potential as effectors of metastatic tumor seeding. We will detail cells poised to disseminate from the primary
tumor into circulation and seed metastatic sites combining protein, multi-omic analyses and functional behavioral
analyses. A focus on a stage II and late stage colorectal cancer cohorts support analyses across the disease
axis, with an emphasis on stage II CRC patients with undetected micrometastases at the time of diagnoses.
Evaluation of the lifecycle of the hybrid cell from primary tumor to dissemination will provide biologic insight into
the metastatic process with great potential to impact the management and care of patients with cancer.

Public health relevance
Project Narrative Metastatic disease accounts for >90% of cancer-related deaths worldwide, yet this phase of tumor progression is the least biologically understood. To address this challenge, we will integrate newly developed protein phenotyping technology, sophisticated computational biologic analyses, and an understudied neoplastic hybrid cell that represents the largest tumor population in peripheral blood. Our proposed study will explore the biology underlying the lifecycle of a disseminated neoplastic hybrid cells providing new insights into metastatic disease effectors, identification of pre-metastatic tumor states, and evaluation of a stage II colorectal cancer patient cohort in need of new approaches for treatment stratification to impact their survival.